Translational Pathology and Data Analysis Core (TPDAC)

SUMMARY
Accomplishment of the translational and basic science aims of each Translational and Basic Science of
Adenomas Center (TBAC) project will depend on reliable access to the biospecimens, analytic and data services
that will be provided by the Translational Pathology and Data Analysis Core (TPDAC). The TPDAC facilitates
the utilization of existing resources/facilities in the University of Wisconsin (U WI) Department of Pathology &
Laboratory Medicine Translational Research Initiatives in Pathology (TRIP) Laboratory and Fred Hutchinson
Cancer Research Center (FHCRC) along with faculty expertise in the U WI Departments of Pathology &
Laboratory Medicine, Radiology, Oncology and Biostatistics. The complementarity between the populations at
two public research institutions will allow intra- and inter-TBAC investigators to access biospecimens that will not
only advance our knowledge of early colonic lesions, but also ensure adequate representation of patient diversity
in our studies. In addition, TBAC U54 Project studies require analytic resources that use innovative technologies,
such as Digital Spatial Profiling, Single cell Seq, and multispectral imaging. The availability of technology and
expertise in the UW TRIP Lab permits quantitative analysis of multiple molecular targets at single-cell resolution
in a single tissue section. Finally, the commitment of the TPDAC ensures consistent implementation of big data
analysis and statistics to enhance the TBAC’s translational goals, which include providing high-dimensional
datasets for cross-TBEL collaborative studies. Under U54 support, the TPDAC will contain the expertise needed
to help identify, optimize and implement the newest technology for early colon lesion research.
The TPDAC draws upon elements from biospecimen science, research pathology, imaging and data analysis
services units at U WI, UWCCC, FHCRC, and Univ of Washington. The additive and complementary expertise
and resources at the two research institutions will be capable of providing investigators of early colonic lesions
in all of the TBAC Projects with a wide array of pathology and analytic services to support translational and basic
research. The Specific Aims are:
Aim 1) To collect, organize, and distribute annotated polyps and imaging data from computed tomography
colonography (CTC) to facilitate research in early colonic lesions.
Aim 2) To support multi-omics analysis of nonadvanced and advanced colonic adenomas and matched normal
colon samples from the ColoCare and GiCaRes cohorts.
Aim 3) To support spatial and molecular profiling projects with a comprehensive array of pathology services and
analytic tools.
Aim 4) To support analysis and integration of high dimensional data generated from multi-omics studies.